School-Located Vaccination to Reduce Inequities in Vaccination Uptake Among Historically Excluded Populations in Colorado

Health disparity populations are more likely to face barriers to immunization in traditional medical settings.
Specifically, people from minoritized racial/ethnic groups, residents of underserved rural areas, and
households with less advantaged socio-economic status are more likely to lack a primary care medical home,
report logistical challenges accessing medical offices (e.g., lack of transportation, clinic hours, long wait times),
and live in areas with poor access to primary care. Prior to the COVID-19 pandemic, school-located
vaccination (SLV) had been successfully used for routine and pandemic (H1N1) vaccines to overcome some of
these access barriers. SLV can occur through School-Based Health Centers (SBHCs) or School-Located
Vaccine Clinics (SLVCs). SLVCs are time-limited events focused on the mass delivery of one or more
vaccines. They can be led by a school nurse, coordinated through an SBHC, if available, or conducted in
partnership with local health systems or health departments. As only 13% of public school students in the
United States had access to an SBHC in the 2016-17 school year, SLVCs play an important role in extending
the reach of SLV. Recently, schools gained substantial experience with SLVCs due to the urgency of the
pediatric COVID-19 vaccine roll-out. Because most SBHCs are located in urban, low-income, and
racially/ethnically minoritized communities and SLVCs typically provide vaccines free of cost to all students
regardless of insurance status, they are often assumed to improve health equity. However, there have been no
systematic investigations of the full scope of SLV models (SBHCs, SLVCs independent of an SBHC, and
SLVCs run by SBHCs) to determine whether locating vaccination services in schools increases immunization
rates in health disparity populations. To fill this critical gap, this study will apply quasi-experimental methods,
microsimulation modeling, and a modified positive deviance approach grounded in implementation science to
examine the impact of the three models of SLV (SBHCs, SLVCs, and both) on routine, influenza, and COVID-
19 vaccination rates among school-aged children in Colorado, overall and for health disparity populations. We
aim to: (1) Describe SLV models (SBHCs, SLVCs, and both) in Colorado from 2018-2024, the local context in
which they were implemented, and how model and school characteristics changed over time; (2) Estimate
causal impacts of SLV models on routine, influenza, and COVID-19 vaccine uptake among school-aged
children (5-17 years) from 2018-2024; (3) Simulate potential local- and state-level impacts of SLVCs on
routine, influenza, and COVID-19 vaccine coverage among all students in Colorado and members of health
disparity populations; and (4) Qualitatively investigate contextual barriers to and facilitators of recent SLV
implementation in Colorado. Study findings will be immediately actionable for SLV implementers and
policymakers seeking to reduce vaccination disparities among school-aged children and adolescents.

Public health relevance
This study will examine the impact of school-located vaccination (SLV) on routine, influenza, and COVID-19 vaccination rates among school-aged children and adolescents in Colorado from 2018-2024, overall and among health disparity populations. We will use propensity score matching in extended Cox models to assess the causal impact of three SLV models: school-based health centers (SBHCs), school- located vaccination clinics (SLVCs) independent of an SBHC, and SLVCs run by an SBHC, on students’ vaccination likelihood; simulate potential local- and state-level impacts of SLVCs on routine, influenza, and COVID-19 vaccine coverage among all students in Colorado and members of health disparity populations; and use the Consolidated Framework for Implementation Research and a modified positive deviance approach to examine contextual factors influencing recent implementation and success of the three models of SLV. Study findings will be immediately actionable for implementers and policymakers in Colorado and across the country as they work to address vaccination inequities exacerbated by the COVID-19 pandemic and prepare for future public health emergencies.